Network Analysis of Family Caregiving for People Living with Dementia: A Survey of Caregiver Networks in Clinical and Community Settings

Project Summary
Older adults with Alzheimer’s disease rely on family caregivers for the majority of their care. These caregivers
are a crucial first line of defense for management of cognitive health problems, but caregivers often report
being overwhelmed and underprepared for their role. Research and interventions targeting caregivers often
limit their focus to one primary caregiver, typically a spouse or child, but most caregivers enlist secondary
caregivers for additional support including family, friends, and health professionals. Ongoing changes in family
structure, including an increase in adults aging without spouses or children, raise questions about who will step
into a caregiving role for many aging Americans. Considering these trends, little is known about the
prevalence, roles, or health-related consequences of secondary caregivers. In this R21 proposal we describe
an exploratory study of the caregiver networks of a sample of older adults living with Alzheimer’s disease and
related dementias (ADRD), including informal and professional caregivers outside of the primary caregiving
dyad. Our objective is to apply insights from social network analysis (SNA) to improve understanding of the
real-world caregiver networks that older adults coping with memory disorders rely on day-to-day.
Aim 1. Identify consequences of family structure for caregiver network participation and composition.
We will examine how dementia caregiving tasks are shared among kin, non-kin, and professionals, and how
caregiver networks vary across diverse social and medical contexts. Aim 2. Analyze associations between
caregiver network characteristics and caregiving outcomes. Outcomes include the quality and costs of
care, use of formal services, and primary caregiver burden and mental health.
Developing our understanding of the family caregiver networks providing support to people living with ADRD
has advantages for healthcare providers, policymakers, and researchers. First, improved characterization of
caregiver networks will support identification of at-risk individuals who lack needed support. Our approach may
also help to identify novel intervention targets outside of the primary caregiving dyad. Second, overlooking the
labor of secondary caregivers may have led policymakers to overestimate the ability of family members to
absorb the growing national burden of care for Alzheimer’s disease. Precise estimates of the dementia
workforce are essential for evaluating the costs of healthcare policy options in an aging nation. Third, we hope
to develop a network science model for caregiving that can be adapted to other illness and treatment contexts.

Public health relevance
Project Narrative This exploratory project uses social network analysis (SNA) to measure the composition and consequences of caregiver networks for community-residing adults with Alzheimer’s disease and related dementias (ADRD). An SNA-based survey of primary caregivers from diverse backgrounds will provide a rich portrait of the social context of family caregiving in ADRD, including a detailed census of secondary caregivers who are often overlooked in caregiver research, health policy, and interventions. Results will indicate whether variations in caregiver networks help explain disparities in caregiving outcomes such as quality and costs of care, use of formal services, and primary caregiver burden.